PHARMACOLOGY OF CYCLOPHOSPHAMIDE AND OTHER ALKYLATORS

The objective of the proposed research is ultimately to improve the therapy of malignant disease with antitumor alkylating agents. We propose to accomplish this objective through a better understanding of the pharmacology of the drug cyclophosphamide, as well as other clinically useful alkylating agents. Our goals are: a) To design more effective and selective analogues of cyclophosphamide, based on an understanding of the chemistry and pharmacology of this drug; and b) To utilize cyclophosphamide or appropriate derivatives more rationally, based on a better understanding of the complex pharmacodynamics of this drug. To this end we propose: a) To continue our studies on the chemistry and metabolism of cyclophosphamide and its metabolites; b) To investigate the interaction of the metabolites with normal and tumor cells, including cytotoxicity, transport across the cell membrane, alkylation of DNA, crosslinking of DNA, and effects on cellular metabolism; and c) To expand our studies on the clinical pharmacokinetics of cyclophosphamide and metabolites. Similar studies will be carried out with other alkylating agents, such as L-phenylalanine mustard, to compare the properties of these alkylating agents with those of cyclophosphamide.